A novel ctDNA analysis solution for the next-generation of liquid biopsy assays

PROJECT SUMMARY/ABSTRACT
Detection and analysis of the mutations and methylation changes that occur in cancer cells is a foundational
element of cancer research and care. Rapidly emerging technologies such as ‘Liquid Biopsy’ (LBx) based on
circulating tumor DNA (ctDNA) are hindered by the limitations of current DNA analysis methods, primarily next-
generation sequencing (NGS). These limitations include low accuracy and the requirement for indirect, even more
inaccurate methods to readout methylation.
To address this challenge, XGenomes is developing an entirely novel DNA analysis platform that directly reads both
mutations and methylation changes, achieving accuracy for each over 100x greater than current DNA sequencing
platforms. This technology is based around measuring the kinetic binding of a repertoire of short, fluorescently
labelled oligonucleotide probes, using super-resolution microscopy. The changes in binding kinetics allow for direct
measurement of methylation, without the need for prior bisulfite conversion or similar treatment. As each
nucleotide of the target DNA is measured by multiple overlapping probes, this technique provides unprecedented
accuracy. This technology will facilitate a transformative advancement in both cancer research and clinical care.
XGenomes has demonstrated all key elements of the platform in principle. In this project, the platform will be further
developed to the point where proof-of-concept (POC) assays in cancer therapy selection and methylation analysis
can be conducted.
Specific Aim 1 involves integrating hybridization capture into XGenomes' workflow. Specific Aim 2 will focus on
designing and optimizing a targeted methylation assay for the BRCA1 gene promoter—a critical factor in breast
and ovarian cancer.
The tests developed in this project will act as proof of concept for broader applications, laying the foundation for
development of more complex assays. This validation of XGenomes’ platform achieved in this project will help
secure further investment, both federal and venture, thereby accelerating the platform's application across
cancer research and care, and ultimately transforming the field.

Public health relevance
PROJECT NARRATIVE Detection and analysis of circulating tumor DNA (ctDNA) in blood represents a pivotal opportunity for non-invasive cancer detection and monitoring, but current technology limitations hinder its clinical application. XGenomes' innovative ctDNA analysis technology has the potential to revolutionize ctDNA-based cancer testing by enabling the detection of rare ctDNA molecules. This technology will enable the development of highly sensitive and specific ctDNA-based tests, leading to earlier and more accurate cancer detection, along with better cancer monitoring and treatment.